Environmental Carcinogens Induce Minority MOMP to Initiate Carcinogenesis in Lung Cancer and Mesothelioma whileMaintaining Apoptotic Resistance via Mcl-1

ABSTRACT / SUMMARY
Lung cancer and mesothelioma accounted for over 200,000 new diagnoses in 2020. The common link between
these cancers is chronic exposure to the known environmental carcinogens cigarette smoke and asbestos. They
are difficult to treat because they typically harbor over 3000 mutations from the repeated insults from
carcinogens. Targeting one mutation is circumvented through new mutations and bypass pathways. For this
reason, targeting the mitochondrial pathways represents an important and novel approach because they
are downstream of oncogenic driver proteins and pathway mutations.
Recently, we have shown that chronic exposure of pre-neoplastic, Barrett’s esophageal cells to bile salt induced
malignant transformation through a mechanism termed, ‘Minority MOMP (mitochondrial outer membrane
permeabilization)’. MOMP is regulated by the B-cell lymphoma-2 (Bcl-2) family of proteins that are divided into
pro- and anti-apoptotic proteins that interact at Bcl-2 homology-3 (BH3) domains. Minority MOMP partially
activates the intrinsic pathway of the apoptotic machinery to levels that do not result in cell death but instead
promote genomic instability, cellular transformation, and tumorigenesis. ‘Minority MOMP’ also resists apoptosis
through the upregulation of the anti-apoptotic protein, Mcl-1. When we targeted Mcl-1, Minority MOMP shifted
from the sub-lethal mitochondrial activation to frank apoptosis and the tumor cells died. What is not known is
whether the Minority MOMP mechanism widely promotes malignant transformation from different environmental
carcinogens (smoke and asbestos). Currently, the major obstacle in the treatment of thoracic cancers is
overcoming resistance to therapy. If Minority MOMP is a common mechanism that promotes
carcinogenesis while simultaneously enabling resistance to apoptosis, then disruption of Minority
MOMP by targeting Bcl-2 proteins provides a therapeutic strategy to overcome treatment-refractory
cancers.
The goal is to determine whether ‘Minority MOMP’ is a generalizable, oncogenic mechanism associated with
environmental carcinogens. We will determine whether this mechanism is associated with upregulation of
clinically-targetable bcl-2 proteins. Normally, the oncogenic mitochondria enable cancer cell survival; if the sub-
lethal activation of the apoptotic machinery is unchecked, the tumor cell will no longer resist apoptosis. These
mitochondrial alterations should restore therapeutic susceptibility to treatment-refractory, thoracic cancers. Our
hypothesis is that chronic exposure of environmental carcinogens induces both carcinogenesis and resistance
to apoptosis through Minority MOMP. If Minority MOMP is an oncogenic mechanism that requires upregulation
of anti-apoptotic proteins for cancer cell survival, then shifting Minority MOMP to apoptosis by blocking the
compensatory anti-apoptotic proteins provides a novel and clinically-actionable treatment strategy.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it identifies a new approach for highly lethal lung cancer and mesothelioma, which are caused by repeated, long-term insults such as smoking and asbestos. Instead of targeting the ever-changing mutations of cancer cells, the proposed strategy targets the mitochondrial engine of the cell, rendering tumor cells vulnerable to standard therapies. This project is relevant to the NIH mission to discover new tumor targets and agents.